Core A: Administrative

Modified Project Summary/Abstract Section

The Administrative (Admin) Core (Core A) is the coordinating hub of the Emory CFAR with responsibility for scientific leadership, effective stewardship of resources, investment in innovative HIV research initiatives, and support for the recruitment of Early-Stage Investigators. This is accomplished through five science cores (Prevention and Implementation Sciences, Clinical Research, Biostatistics and Bioinformatics, Virology and Molecular Biomarkers, and Systems Immunology) and two Scientific Working Groups. Through annual strategic planning, we will evaluate Core services and leverage resources to ensure the evolving needs of HIV researchers are met. The Admin Core will continue funding developmental awards and promote training programs to move early-stage investigators to independent funding through the Developmental Core. We will strive for effective community engagement in all aspects of the CFAR through greater integration of and capacity building within the CFAR Community Liaison Council. Building on their trailblazing work, we will promote multidirectional stakeholder engagement to build and sustain trust in HIV research. The Emory CFAR is Co-Directed by three distinguished HIV investigators providing complementary expertise across all major areas of HIV research at Emory. Dr. Carlos del Rio is contact PI and Co-Director for Clinical Science, Dr. Colleen Kelley is MPI and Co-Director for Prevention Science, and Dr. Ann Chahroudi is MPI and Co-Director for Basic Science. In the next project period, the Admin Core will be responsible for ensuring that all supported activities are responsive to the CFAR strategic planning priorities, are broadly advertised, are easily accessible to investigators, and are regularly evaluated to ensure they are optimally responsive to the evolving needs of CFAR investigators. To accomplish this, the Core proposes the following specific aims: Aim 1. Provide scientific leadership and coordinate activities that support CFAR Members as they advance groundbreaking HIV research across the entire scientific spectrum of NIH-defined priority research areas to end the epidemic for all . Aim 2. Allocate resources effectively and judiciously to support six Cores and two Scientific Working Groups, providing cutting-edge tools and services to elevate multidisciplinary and translational HIV research. Aim 3. Develop the next generation of outstanding HIV investigators through innovative developmental grant programs, leadership development and mentoring in all aspects of the Emory CFAR. Aim 4. Utilize intentional communication and dissemination strategies to promote multidirectional stakeholder engagement between HIV researchers and the communities we seek to serve.